Identifying the metabolic requirements for the TCA cycle in embryonic development

PROJECT SUMMARY
Embryonic development involves complex changes in cell proliferation, macromolecule synthesis, and nutrient
availability, all of which impose different metabolic demands. Accordingly, cells must remodel central metabolic
pathways during early development, but the metabolic requirements of early differentiation and how metabolic
pathways are reprogrammed during this critical developmental window remain poorly understood. Recently,
our lab demonstrated that the tricarboxylic acid (TCA) cycle, a central metabolic hub critical for energy
production and provision of biosynthetic intermediates, undergoes dynamic shifts during cell state transitions.
Using mouse embryonic stem cells (ESCs) as a model system, we found that naïve pluripotent ESCs, which
mimic the pre-implantation epiblast, predominantly rely on the conventional configuration of the TCA cycle, in
which citrate is oxidized within the mitochondria. In contrast, more committed ESCs, including those mimicking
post-implantation epiblast-like states, preferentially export citrate from the mitochondria, bypassing canonical
TCA cycle oxidation. Accordingly, aconitase 2 (ACO2), a key enzyme in the TCA cycle that initiates the
catabolism of citrate within the mitochondria, is essential for maintaining the naïve pluripotent state but is
dispensable in more differentiated cells. Notably, loss of ACO2 function in humans is linked to severe
neurodevelopmental disorders, and mice with heterozygous ACO2 mutations fail to produce viable
homozygous null pups. Together, these results indicate that ACO2 plays a context-specific role in early
development, but what metabolic outputs of ACO2 support development and the developmental consequences
of ACO2 disruption remain unknown. The goal of this project is to determine the role of ACO2 in maintaining
naïve pluripotency and supporting early embryonic development. Our preliminary data indicate that ACO2 is
dispensable for both energy production and generation of macromolecular precursors; rather, ACO2 is
essential to prevent the accumulation of toxic citrate in highly oxidative cellular states. Aim 1 will combine
genetic and pharmacologic approaches to determine whether increased citrate production in naïve ESCs
induces dependence on ACO2 for citrate clearance and cell fitness. Aim 2 will reveal the developmental
consequences of ACO2 loss in vivo using newly generated Aco2+/- mice. We will genotype embryos from
Aco2+/- crosses to determine the stage at which Aco2-/-embryos lose viability. Based on these findings, we will
isolate Aco2-/- embryos before lethality and investigate the impact of ACO2 loss on cell fate specification,
proliferation, and cell death using immunofluorescence techniques. These studies will enhance our
understanding of how TCA cycle outputs support early embryonic development. The training plan outlined in
this proposal will be completed under the guidance of Dr. Lydia Finley and Dr. Anna-Katerina Hadjantonakis,
experts in metabolism, stem cell biology, and embryology. The excellent environment and comprehensive
training proposed will prepare the applicant for future success as an independent academic researcher.

Public health relevance
PROJECT NARRATIVE During embryonic development, cells experience changing nutrient environments and altered metabolic demands, raising the possibility that continuous metabolic remodeling is required for normal development. We have shown that flow of carbons into the tricarboxylic acid (TCA) cycle, a central metabolic hub of the cell, changes as cells differentiate, but why these changes occur and what specific TCA cycle outputs support specific developmental states is unknown. By focusing on one key enzyme of the TCA cycle, aconitase 2 (ACO2), which is specifically required for proliferation of early epiblast-like cells in vitro, we aim to uncover how the TCA cycle supports different embryonic cell types and what outputs of the TCA cycle are required for cell state transitions in development.